Molecular Pathogenesis of the Hamartoma Syndromes

Project Summary/Abstract
Please see each project/core for individual Project Summary/Abstract

Public health relevance
Project Narrative Please see each project/core for individual Project Narrative